The Role of Perilipin 2 in Macrophages after Experimental Spinal Cord Injury

PROJECT SUMMARY/ABSTRACT Spinal cord injury (SCI) leads to permanent motor and sensory loss that is
exacerbated by persistent inflammation months after the injury. After SCI, monocyte-derived macrophages
(MDMs) infiltrate the lesion to aid in cellular debris clearance. However, this response is emerging as a double-
edged sword. Lingering debris inhibits repair and plasticity while clearance of the debris by infiltrating MDMs
induces a proinflammatory and damaging phenotype. Clearance of cholesterol-rich myelin debris causes
MDMs to resemble proinflammatory foam cells both phenotypically and morphologically. Foam cells are lipid-
laden macrophages with numerous lipid droplets (LDs) that form when excessive cholesterol uptake
overwhelms cholesterol metabolism. Foam cells also drive chronic inflammation in atherosclerosis and non-
alcoholic steatohepatitis (NASH). Foam cells persist chronically in the injured cord and may contribute to the
sustained proinflammatory lesion environment. However, their role in the chronic inflammatory state is poorly
understood. Therefore, elucidating the effect of foam cell formation after SCI is integral to understanding the
contribution of MDMs to injury pathology. Preliminary and published data identify Perilipin 2 (Plin2) as a key
differentially upregulated gene in both infiltrating MDMs after SCI and foam cells in atherosclerosis. Plin2 is
essential in regulating the formation and storage of cholesterol (i.e., lipid droplets (LDs)) in macrophages as
lipid metabolites are either exported from these cells or stored in LDs. Plin2 coats LDs, sequesters them in the
cytosol and prevents lipolytic enzymes from accessing their cargo. Reducing Plin2, may, therefore, reduce LD
accumulation and mitigate foam cell formation after SCI. In models of atherosclerosis and NASH, Plin2
deficient mice produced fewer foam cells and were protected from atherosclerotic plaque formation and
cirrhosis, respectively. To understand the effects of Plin2 upregulation in MDMs after SCI a novel targeted
deletion of Plin2 using a LysMCre/lox system will be employed. Using this mouse model, this project will
determine (1) the role of Plin2 in myelin-induced foam cell formation using an in vitro approach and (2) the
effects of targeted Plin2 deletion in MDMs on foam cell formation, inflammation, and locomotor recovery after
experimental. These experiments will test the hypothesis that cell-specific Plin2 ablation in MDMs suppresses
foam cell formation after SCI, inhibits inflammation, and promotes functional recovery. If successful, this project
will provide novel insight into how CNS macrophages metabolize myelin and may provide new therapeutic
targets to improve SCI recovery by resolving chronic intraspinal inflammation. Through the completion of this
training grant, the PI will receive ample training regarding the implementation of project management,
responsible conduct of research, and the dissemination of findings. This training will provide the PI with the
skillset necessary to carry out the specific aims and lay the foundation for the PI to become an independent
physician-scientist with an extramurally supported research portfolio in the field of neurotrauma.

Public health relevance
PROJECT NARRATIVE Spinal cord injury (SCI) often results in permanent paralysis and expensive health care costs for individuals and their families. After SCI, normal repair processes are limited by ineffective clearance of lipid-rich cellular debris caused by white blood cells (monocyte-derived macrophages) transforming into inflammatory cells thereby limiting recovery. Using a novel transgenic model, this study will examine the role of a potential therapeutic target (Plin2) that may dramatically improve this debris clearance process which will limit inflammation and improve recovery after SCI.